BREATH: Breakthrough Research in Electromyography for the Assessment of Sleep-disordered BreaTHing

Project Summary Abstract
Objectives and Specific Aims: The overarching objective is to develop and validate a diagnostic tool for
obstructive sleep apnea (OSA), Deep Learning-enhanced Transmembranous Electromyography (DL-tmEMG),
to enable convenient point-of-care, and accurate detection of OSA for widespread use by any practitioner
evaluating patients for OSA. In phase 1, this proposal aims to establish feasibility of tmEMG to diagnose OSA
patients with good accuracy and to optimize the DL algorithm. Phase 2 aims to demonstrate generalizability
and accuracy of DL-tmEMG in a diverse population, identifying differences in important subpopulations and the
benefits of multimodal data integration, while progressing regulatory approval.
Health-relatedness: This project addresses the urgent need for efficient and accurate diagnostics for OSA, a
widespread and serious disorder impacting an estimated 1 billion people worldwide, while undiagnosed OSA
costs the U.S. approximately $149.6 billion annually. Successful development of DL-tmEMG will enhance
personalized OSA management and improve healthcare accessibility. Efficient screening for OSA in under-
resourced areas and for patients pre-surgically and perinatally are relevant to this proposal.
Design: Phase 1 Study#1 (9 months) is a case-control observational feasibility study of 60 adult patients.
Phase 2 Study #2 (18 months) involves a large single center prospective observational cohort study of 200
adult patients referred for PSG testing at the UCSD Sleep Center.
Methods: DL-tmEMG is a new diagnostic that incorporates two novel technologies: 1) a non-invasive
transmembranous sensor of muscle activity (tmEMG), and 2) deep learning algorithms applied to EMG signal
to provide an automatic interpretation (EMGNet). The combination of these two innovations obviates the need
for an expert electromyographer, key to allowing for widespread use to fulfill the unmet need for improved
diagnostics in OSA. In Phase 1 Study #1, 30 healthy and 30 patients with moderate to severe OSA will
undergo DL-tmEMG within 30 days of polysomnography. We will compare DL-tmEMG classification results
with PSG results and calculate performance metrics. Phase 2 Study #2 utilizes a similar methodology as
Study #1 but differs in size as well as population pretest probabilities, being a cohort study design. Patients will
undergo DL-tmEMG within 30 days of PSG, which will classify patients as OSA (AHI>5) or non-OSA (AHI<5).
The performance of DL-tmEMG will again be compared with PSG results. Recruitment will be adjusted to allow
performance to be evaluated in important sub-populations.
Results of this prospective study will provide strong evidence for validity and reliability of DL-tmEMG as a novel
diagnostic tool for OSA and will be used to support a multicenter study (a phase IIB proposal) that will further
evaluate the performance of DL-tmEMG across sites and diverse patient populations to meet FDA submission
requirements, as part of a 510(k) premarket notification or a premarket approval (PMA) process.

Public health relevance
Project Narrative We will establish how well a novel, quick, and painless way of measuring muscle activity from the mouth and throat works for detecting sleep apnea. This technology is called transmembraneous electromyography (tmEMG). Leveraging two innovative technologies, a new probe capable of recording muscle activity by lightly touching the muscle, as well as a machine learning model for signal interpretation, we will conduct an initial observational feasibility study in phase 1, followed by a larger observational cohort study in phase 2 to assess the performance of deep learning enhanced tmEMG. The study will address a critical unmet need in sleep apnea diagnostics; the availability of an inexpensive, accurate diagnostic test for screening at point of care in under-resourced areas or pre-operatively, helping to resolve a significant healthcare inequity.